Genomics

PROJECT SUMMARY
The Genomics Shared Resource (G-SR) is a state-of-the-art genomics facility dedicated to providing the latest
genomic research tools at a low cost. The primary focus of the G-SR is to facilitate high-impact cancer research
by SCI members by providing the most advanced genetic and genomic-based tools and standardized assays
using these tools. This goal is accomplished by providing SCI members with unencumbered, comprehensive,
and cost-effective access to these genomics technologies at rapid turn-around times with high-touch, expert
consultation services that cover all aspects of genomics experiments from sample preparation to computational
analysis of data. Major G-SR technologies and services include high-throughput sequencing, single-cell genomic
analysis, spatial genomic analysis, microarray-based analysis, digital and real-time quantitative PCR, multiplex
single-molecule analysis, and all sample preparation services required for these technologies. Expert guidance
with the use of each technology is also provided throughout the entire experimental process, including guidance
with experimental design, data analysis, data archiving and publication. The previous resources of the Stanford
Functional Genomics Facility (SFGF), the Genetics Sequencing Service Center (GSSC), Protein and Nucleic
Acid Facility (PAN), and Genetics Bioinformatics Service Center (GBSC) have been now combined under the
leadership of John Coller, PhD, as the G-SR Director, to provide the full spectrum of services. Michael Snyder,
PhD (PS), is the faculty advisor. Members of all programs regularly use the G-SR, with the heaviest use coming
from the Cancer Biology and Cancer Stem Cells and Cancer Immunotherapy programs. The G-SR contributed
to 46 cancer-focused publications (30 high-impact). The annual budget of the G-SR is $3,652,748, yet the CCSG
request is $183,830. Accordingly, the G-SR leverages extensive institutional support and seeks only 5% from
CCSG funds. The G-SR is focused on the following major scientific aims: (1) to provide state-of-the-art genomics
capabilities, (2) to facilitate the development of novel experimental methods and technologies, (3) to evaluate
and implement cutting-edge genomics technologies for cancer research, and (4) to provide training on genomics
technologies, experimental assays, and analysis methods. Future plans of the G-SR include expanding cancer-
specific bioinformatics support with the addition of one full-time bioinformatician, expanding high-throughput
sequencing and single-cell genomic capabilities.